HEMORRHAGIC SHOCK EFFECT ON GLU-6-PTASE GENE EXPRESSION

Hemorrhagic shock from trauma or other etiologies continues to be a major cause of morbidity and mortality. The initial hyperglycemia seen in shock is followed by hypoglycemia and resuscitation failure. Recent data from our laboratory indicated that hemorrhagic shock acutely affects glucose- 6-phosphatase activity and gene expression. Glucose-6- phosphatase is a key enzyme in the hemostatic regulation of blood glucose concentration, which catalyses the final step in gluconeogenesis and glycogenolysis. We have also demonstrated multihormonal regulation of glucose-6-phosphatase gene expression. In order to study the mechanism of changes of glucose-6- phosphatase gene expression in hemorrhagic shock and resuscitation, we propose to study the hormonal regulation of glucose-6-phosphatase activity and mRNA expression. Hemorrhagic shock will be induced in fasted anesthetized rats by reduction of blood pressure to 4OmmHg and maintained in shock for 30 minutes. Control rats will be anesthetized, cannulated and observed for the same time. The liver and kidney from control, hemorrhagic shock and hemorrhagic shock plus lacated Ringer resuscitated rats will be freeze clamped and stored at -70degreesC for future assay of glucose-6-phosphate, fructose-6-phosphate, glucose-6-phosphatase activity and mRNA abundance. Blood samples will be collected at the same time periods to assay catecholamines, corticosterone, insulin and glucagon concentrations in the plasma. Relatively selective pharmacologic antagonists of hormones will be administered prior to hemorrhagic shock and during resuscitation to observe their effects on glucose-6- phosphatase activity and gene expression. Hepatocyte will be isolated from control, hemorrhagic shock and hemorrhagic shock plus resuscitated rats, and will be incubated with agonists to observe their effects on glucose-6-phosphatase activity and gene expression. The results of this study are essential to understand the molecular basis of deranged metabolism in hemorrhagic shock